Antitumor Assessment

ABSTRACT
The Antitumor Assessment Core provides support for early discovery of effective antitumor agents
and therapeutics. The Core provides resources, professional and technical expertise and advisory services
related to the evaluation of agents with potential therapeutic activity, and works closely with investigators to
establish in vivo mouse models, including Patient Derived Xenograft (PDX) models, for the design and
execution of pharmacokinetic, toxicity and in vivo efficacy studies. The Core also determines the
best formulation, administration route, and treatment schedule for each new compound, either alone or in
combination with other agents. As such, the Core provides a major vehicle to facilitate pre-clinical studies,
including GLP-compliant safety toxicology studies in support of IND applications, and is a major contributor to
the translational mission of the Center. The Core helps investigators to design, plan, and execute their in
vivo experiments, prepare animal protocols and grant applications involving animal studies, and
analyze and summarize data for publication and for IND reporting. Importantly, the Core acts as a
central coordinator for studies involving support from several Core facilities (including Animal Imaging,
Comparative Medicine and Pathology, Tissue Procurement Service, Organic Synthesis, Integrated
Genomics, Radiochemistry and Molecular Imaging Probes, and Molecular Cytology) so that studies are
carried out properly and in a time- and cost-efficient manner.